COGNITIVE PROCESSING REVEALED THROUGH EYE MOVEMENTS

A number of computational models have been developed to account for the visuosensory response properties of MST neurons during the presentation of optic flow field stimuli. We have now collected data that samples the stimulus space at a higher resolution to determine whether MST neurons are sensitive to subtle changes which might indicate a shift in the heading of self movement. These data are being compared to the output of current models about MST response mechanisms (implemented at Bochum) to test those models on data sets that were not previously available. Our goal is to use the results of these comparisons to guide future neurophysiologic experiments, initially using purely visual stimuli, and later integrating non-visual heading cues introduced on the two-dimensional sled. During the last year, we recorded the responses of MST neurons during self-movement with and without optic flow displays. These data provided a basis for developing neural models of sensory integration for self-movement perception and spatial orientation.